Neurological Disease Among 1990-1991 Gulf War and Era Veterans in a Large National Cohort: Onset, Patterns of Occurrence and Association with Deployment Characteristics

The United States deployed more than 690,000 military service personnel to serve as part of a large
multinational military coalition responding to Iraq’s invasion of Kuwait for the 1990-1991 Gulf War. This conflict
was relatively brief and highly successful. Yet, since shortly after it ended, Gulf War veterans (GWVs) and
their advocates have continuously expressed substantial concerns about potentially having increased risk for
developing major debilitating neurological diseases like amyotrophic lateral sclerosis (ALS), brain cancer, and
Parkinson’s disease, or developing them at younger ages because of their PG deployment. Deployed GWVs
are in fact recognized as broadly exposed to numerous potential hazards during deployment that could
potentially influence neurological disease risk ranging from long-burning oil well fires, depleted uranium
munitions, and known neurotoxicants including military grade pesticides, exposure to chemical weapon nerve
agent sarin/cyclosarin in association with destruction of a weapons facility in Iraq, to use of the anti-nerve
agent prophylactic medicine pyridostigmine bromide. We propose to perform the largest and most
comprehensive cohort-based evaluation of GWVs risk of developing major neurological diseases in adults
including ALS, Parkinson’s disease, Multiple Sclerosis, Migraines, Epilepsy, Brain Cancer/Brain tumors, and
Dementia. We propose to leverage and greatly expand on our previously identified nationwide cohort of
~140,000 GWVs (~1/3rd deployed). All are in the VA’s Million Veteran Program (MVP) study, and were
identified for an earlier limited GWAS study on Gulf War Illness or GWI (~30% deployed GWI+ per self-
reported symptoms based on recommended Kansas and CDC diagnostic criteria). We will use multiple
sources of data including linked time-updating VA medical records and databases dating back to 1999, veteran
surveys on medical and risk factor data, Department of Defense data on military service, linked external
healthcare databases like Medicare, language guided narrative medical note searches and electronic medical
review. An expert advisory panel will use clinical guideline criteria to validate all cases. We will employ
longitudinal multivariable modeling to assess if deployment (including specific aspects of deployment like time
or branch/location) or comorbid GWI influence neurological disease risk in GWVs. Our timely study will help
address long-standing veteran concerns, and is responsive to the National Academy of Sciences’ continuing
guidance to the VA to perform critically needed rigorous large-sample cohort studies to address these
concerns.

Public health relevance
For over 30 years, persistent concerns have been expressed by veterans, their advocates and agencies that care for them, and the scientific community that veterans of the 1990-1991 Gulf War (GWVs) may have increased risk of developing neurological diseases potentially because of hazardous exposures during deployment. We will perform an epidemiology study in the large nationwide cohort of GWVs participating in the VA’s Million Veteran Program study to identify and describe all cases of priority neurological conditions (including ALS, MS, Parkinson’s disease, dementia, and brain cancer/tumors) in GWVs. We hypothesize that deployed GWVs will have increased risk of one or more conditions, and that deployed GWVs who have Gulf War Illness (GWI) will have the highest risk and be more likely to be diagnosed at younger ages. Our study addresses long-standing veteran concerns, provides important data for VA healthcare planners, and provides well-described neurological disease cohorts needed for future genetic risk studies.